EVALUATION OF GENETIC ALTERATIONS IN NEOPLASTIC &PRENEOPLASTIC GASTRIC CANCER

Utilizing paraffin-embedded material and the PCR technique, we will be searching for a variety of genetic mutations that may or may not be expressed in gastric cancer and some of the pre-neoplastic lesions, and we will correlate with clinical outcome as well as with other known prognostic factors such as p53 and C-erbB2.